Variations in Hormones During Menopause: Effects on Cognitive and Brain Aging

The broad goal of our continued program of research is to decipher the cognitive and brain effects of transitional
and surgical variants of menopause, including optimizing cognitive aging by discovering efficacious hormone
therapy (HT) options in the context of menopause variations seen in women. This incorporates determining
memory and brain changes as transitional menopause ensues when ovaries are undergoing follicular depletion,
as well as the optimal parameters for interventions subsequent to transitional and surgical menopause variants.
Menopause has been associated with cognitive decline and increased dementia risk. However, factors driving
these outcomes, and which HT parameters alter effects, are undetermined. Importance is underscored given
that most women are living at least one-third of their lives in a menopausal state encompassed by numerous
variations (with or without a uterus, follicular deplete ovaries, or HT). In the current grant period, we had 23
publications; using the rat model, we showed that transitional menopause detrimentally impacted memory, that
effects were most pronounced during perimenopause when follicles were undergoing early depletion, that higher
androstenedione levels were associated with worse memory outcomes, and that short-term hysterectomy (uterus
removal) alone impaired memory. We found that progesterone impaired memory, and that these effects were
modulated by the GABAergic system. We also showed that several clinically-used synthetic progestins impaired
memory, and identified one that enhanced memory: Levonorgestrel (Levo). When taking oral contraceptives or
HT, a woman with a uterus must include a progestin along with estrogens to offset estrogen-induced hyperplasia.
Thus, we performed an individual versus combination study, and showed that 17β-estradiol (E2) and Levo each
enhanced memory when given alone, but impaired memory when given in combination. We also found that E2-
induced cognitive benefits were associated with cholinergic integrity, building on literature showing estrogen-
cholinergic interactions. This renewal addresses critical questions stemming from these collective findings. Aim
1 tests whether varied E2 regimens attenuate memory impairments associated with the perimenopausal
transition, and assesses novel progestins that are anti-androgenic or have minimal androgenicity, with a goal to
find options that do not reverse beneficial E2 effects on cognition and the brain. Aim 2 determines how variations
in menopause type, including hysterectomy, impact cognition and the brain, testing effects of a temporal window,
age, and follicular depletion state. Aim 3 defines how menopause variants and clinically-used HTs interact with
candidate neurotransmitter systems in mechanistic detail, systematically examining GABAergic signaling and
cholinergic circuitry. We combine behavioral, physiological, and neurobiological approaches in the framework of
a blinded and randomized animal model research program to disentangle the complexity of menopause variants
and HT opportunities for neurocognitive enhancement, extrapolating directives explicitly from the clinic.

Public health relevance
PROJECT NARRATIVE The overarching goal of our continued program of research is to use the rat model to understand how variations in menopause and reproductive tract change in females, as well as subsequent hormone therapies mapped on to these variations, impact cognitive and brain aging. Specifically, this renewal addresses whether varied estrogen regimens attenuate the memory impairment we have shown during the perimenopausal transition; assesses novel progestins with a goal to find enhancing options that do not reverse the beneficial cognitive effects of estrogens; and tests the cognitive parameters of surgical variations of the reproductive tract, including a novel hysterectomy model we have shown to impair cognition, compared to transitional menopause. To test neurocognitive mechanisms, brain changes with menopause variants and hormone therapies are tested via evaluations of GABAergic signaling and cholinergic long-range circuitry between the basal forebrain, hippocampus, and frontal cortex, brain areas shown to be related to learning and memory.